Development of a multi-channel radiofrequency and pulsed field energy source generator for cardiac ablation

ABSTRACT
Untreated cardiac arrhythmias can damage the heart, brain, or other organs, and lead to death. Catheter ablation
therapy for cardiac arrhythmias is vastly underpenetrated due to its less-than-ideal safety and efficacy profile,
procedural complexity, and accessibility. Currently, all ablation catheters are based on the same design
principles with similar safety and efficacy outcomes. Sirona’s proprietary technology improves the ablation
procedures by blocking the passage of energy to the blood and surrounding structures and delivering the ablation
energy in a more precise and predictable manner to the target tissue. Sirona’s Vector Catheter is fully developed
and, in both ex-vivo and in-vivo animal studies, achieves the same size ablation lesions as the leading catheter
in the market while utilizing substantially less power and irrigation volume. This reduces off-target tissue damage,
enables Sirona’s catheter to provide a more accurate measurement of the tissue temperature, thereby delivering
energy to the intended target more precisely and safely. Sirona’s Multi-Modal Catheter is multi-electrode catheter
designed to address several practical challenges in the ablation space and reduce the procedure complexity,
which ultimately will result in increased accessibility of this therapy. This catheter’s unique features include multi-
configuration, insulated electrodes, axial rotation, variable array diameter, and lesion overlap control. Both
catheters require a customizable, multi-channel, dual energy source generator for selective delivery of ablative
energy. The generator must deliver energy in a programmable fashion, of the appropriate magnitude and
waveform to the unique arrays of electrodes, switch seamlessly between radiofrequency (RF) and pulsed field
(PF) energy sources, and monitor temperature, impedance, and other ablation parameters. These features are
not available in commercial generators; therefore, Sirona must develop its own custom generator as an integral
part of its ablation system. The goal of this R61 phase is to develop and validate hardware to interface Sirona’s
catheters to RF and PF generator platforms and establish signal boundaries and parameters for safe and
effective delivery of ablative energy to the target subject. This will be accomplished through: Aim #1: Develop
hardware for interfacing Sirona’s catheter(s) with PF and RF generator platforms, Aim #2: Establish signal
parameters for safe delivery of the energy, and Aim #3: Establish signal parameters for effective delivery of the
energy and dose response data. Accomplishing these milestones allows Sirona to transition to the R33 phase,
where Sirona will develop the specifications for optimal hardware and user interface. The R33 phase consists of
Specific Aim #4: Develop the hardware allowing the selection of energy source and output channel for delivery
of the ablative energy, Aim #5: Develop product requirements for the custom, multi-channel, dual energy source
product, Aim #6: Develop first article custom generator and validate the product against the product
requirements, Aim #7: Demonstrate safety, efficacy, and efficiency of the custom generator in acute animal
studies. Successful completion enables Sirona’s custom generator to be used for future animal and FIH studies.

Public health relevance
NARRATIVE Catheter ablation treatment for heartbeat irregularities is a rapidly growing treatment, but it has a less-than-ideal safety and efficacy profile and procedural complexity. Sirona has developed a novel catheter that has been shown to have equal efficacy to the current leading catheter in the market, while improving safety and efficacy. This project will develop and validate the generator needed to support the use of the catheter, which can ultimately lead to safer, more effective, and more efficient technologies available for clinical use.